Methods Core

Abstract/Project Summary – METHODOLOGY CORE
The Methodology Core for the Center for Perioperative Mental Health will support the iterative adaptation,
implementation, and evaluation of a mental health behavioral and pharmacological intervention bundle in real-
world care settings. Using a collaborative planning approach, enabled by stakeholder advisory boards (SABs),
we propose to address three specific aims: (1) establish an infrastructure to adapt, plan, implement and
empirically evaluate an intervention bundle for depression and anxiety among three older adult surgical patient
populations and contexts; (2) develop and maintain a comprehensive informatics infrastructure to support
seamless data collection, management, and use for the various center projects; and (3) launch an integrated
research operations infrastructure to provide training, supervision, expert consultation, and management of
projects using mixed methods. Our transdisciplinary team-based approach will allow us to “build and grow the
bench” of perioperative mental health research.

Public health relevance
Project Narrative – METHODOLOGY CORE The Methodology Core for the Center for Perioperative Mental Health engages a transdisciplinary team to support the translational research needs for the implementation of patient-centered mental health intervention bundles in real-world care settings. The Methodology Core will support the development and implementation of the proposed behavioral and pharmacological intervention bundle; employ a robust informatics infrastructure for the delivery and management of these interventions; and provide the research support for empirical evaluation of the intervention bundle using mixed-methods.